Community Engagement Core

PROJECT SUMMARY – Community Engagement Core
The Community Engagement Core (CEC) will foster a culture of collaboration among environmental health
scientists, community organizations, environmental justice experts and environmental health-related public
agencies to create and sustain multi-directional partnerships for environmental health research that are
responsive to the environmental health needs and concerns of the most vulnerable communities in California's
Central Valley. This region, considered to have the most productive agricultural industry in the country, also
leads the nation in areas of concentrated poverty, environmental contamination, and poor environmental health
conditions. Building from a foundation of strong community partnerships developed in the last four years, the
CEC’s activities for the next cycle will include: 1) building greater Community Stakeholder Advisory Committee
(CSTAC) leadership into CEC and EHSCC activities; 2) expanding, modifying, and refining trainings from the
last cycle in order to reach a wider audience and continue strengthening individual community-engaged
research partnerships; 3) developing innovative and impactful communication strategies that increase
environmental health literacy, empower communities to understand and use science, and drive the translation
of EHSCC research into policy change and other health-protective action; and, 4) evaluating the efficacy of
CEC programs for continuous improvement and contribution to the scholarship of community engagement. The
CEC will interact with all programs and cores within the EHSCC, serving to connect EHSCC leadership and
investigators to the interests and needs of disadvantaged communities in the Central Valley. Integration with
the Pilot Project Program will focus upon developing community-responsive pilot projects, for which the CEC
and CSTAC co-chairs will serve as proposal reviewers and the CEC will provide continuous support to pilot
investigators throughout their projects. The CEC and Administrative Core will work together to plan and
coordinate CEC/CSTAC directed events, produce and disseminate outreach materials, and coordinate
engagement between the EHSCC and non-academic stakeholders. Integration with the Integrated Health
Sciences Facility Core (IHSFC) and Exposure Core will be enhanced by new topic-specific working groups;
CSTAC member participation on these working groups will create opportunities to identify potential community
engagement and research-to-policy activities.